Quantitative EMG as a Predictor of Functional Recovery in SCI

DESCRIPTION (provided by applicant): Project Summary/Abstract. Motor and sensory loss in upper and lower limbs due to spinal cord injury (SCI) is devastating, and predicting functional recovery is of utmost importance to veterans with SCI. Even a slight improvement in the American Spinal Injury Association (ASIA) scale can correlate with large functional gains. In current standard practice, functional recovery is predicted solely based on clinical examination. This assessment is somewhat subjective and does not address underlying pathophysiology. Improving our ability to predict functional gains can help us better tailor rehabilitation programs to maximize neurological return. This pilot project will evaluate the utility of quantitative EMG to predict the extent of functional recovery in the upper limb in SCI. We have developed quantitative EMG decomposition methods for measuring the waveforms and firing patterns of individual motor units to obtain information about denervation and impaired motor control. Quantitative EMG can provide an objective, quantitative assessment of specific spinal segments and peripheral nerve tracts that cannot be revealed by clinical exam alone. Patients admitted to the SCI Center with acute cervical SCI will receive a physical exam and an EMG exam during their initial stay and at 3 and 12 months post injury. The tests will target two muscles in each of the C4-C8 myotomes. For the physical exam, the extent of muscle involvement will be estimated according to the ASIA scale. For the EMG exam, 10-second-long signals will be recorded during moderately low levels of voluntary contraction at 4 sites in each muscle. The EMG signals will be analyzed off-line using EMG decomposition, and indices of denervation and impaired motor control, including incidence of fibrillation potentials, mean motor-unit-action-potential amplitude, recruitment stability, and firing-rate variability, will be tabulated. The data will be analyzed with respect to these questions: Q1: How do quantitative EMG parameters change during the first year after spinal cord injury? Q2: Can quantitative EMG parameters measured during the three months after injury predict functional recovery as measured in terms of dynamometry and functional scores at 12 months after injury? This study will provide preliminary data for a subsequent investigation of the ability of quantitative EMG to identify patients who will respond favorably to specific rehabilitation modalities, such as electrical stimulation. It will also provide information about motor unit firing patterns and impaired motor control in persons with SCI that is currently lacking from the literature.

Public health relevance
Project Narrative In the current standard of practice, recovery from a spinal cord injury is predicted based on clinical examination. This project will assess whether an electromyography examination that assesses electrical activity in the muscle 3 months after a spinal cord injury can improve our ability to predict a patient's level of recovery after one year. This knowledge will be important for tailoring rehabilitation programs to individual patients in order to facilitate recovery. Such information would be of great relevance to the VA SCI healthcare mission to maximize functional independence and quality of life in persons with spinal cord injury. Advances in prognostic accuracy especially in the acute phase of rehabilitation may translate into more efficient and effective care and better overall outcomes. VA